EFFICACY OF LOW MOLECULAR WEIGHT HEPARIN IN TREATMENT OF THROMBOSIS

This investigation is designed to test whether low molecular weight heparin is safer or more effective than heparin in treating thrombosis in children.